Assessing Capacity to Address Obesity for Cancer Prevention and Control

PROJECT SUMMARY
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT-CA-
25-004. Nebraska faces disproportionately high rates of several cancers and one of its major risk factors,
obesity. Obesity is particularly common among Nebraska’s at-risk populations, including rural inhabitants,
positioning the state as a unique setting to investigate determinants of cancer risk. Mitigating obesity is
achievable through a multi-modal approach, encompassing not just individual behaviors (e.g., nutrition,
physical activity) but broader social, environmental, and policy influences, especially for populations
disproportionately affected by obesity and related cancers. Therefore, this study proposes a community-
informed approach that integrates Policy, Systems, and Environmental (PSE) changes and Whole Systems
Approaches (WSA) to address obesity and its upstream determinants. By engaging partners from multiple
sectors, including healthcare systems, academic institutions, community leaders, and public health agencies,
we aim to identify and prioritize context-specific interventions that reflect the needs and capacities of Nebraska
communities. This proposal will: 1) Analyze the prevalence of obesity and its behavioral determinants (e.g.,
diet, alcohol consumption, physical activity patterns) across demographic groups and geographic regions in
Nebraska, with a focus on rural populations; 2) Conduct a comprehensive environmental scan to identify and
engage key partners across distinct sectors relevant to obesity prevention and treatment, including community
leaders, healthcare systems, academic institutions, and representatives of the State and County Health
Departments; and 3) Conduct qualitative research through community-engaged convenings across the breadth
of our catchment area to identify priorities, attitudes, and beliefs surrounding obesity and its behavioral and
environmental determinants. Specifically, we will partner with Nebraska Extension to hold listening sessions
with representative communities across the state to understand unique barriers and efforts used to combat
obesity. These aims will result in a cataloged and searchable document that identifies current and ongoing
efforts across the state and convene key community partners, including the Fred and Pamela Buffett Cancer
Center’s Community Advisory Board, to facilitate collaboration and inform future obesity prevention strategies.
This comprehensive overview will serve as a valuable tool for leaders in obesity prevention, enabling them to
identify potential synergies, avoid duplication of efforts, and develop more targeted and effective obesity
prevention interventions in Nebraska. This work will lay the foundation for sustainable strategies tailored to
Nebraska’s unique context, ultimately fostering future multi-sector interventions aimed at lowering obesity rates
and improving cancer control across the state.

Public health relevance
PROJECT NARRATIVE Nebraska faces high rates of several cancers when compared to the rest of the US, including the state’s alarmingly high obesity levels, especially among rural groups. This study proposes a comprehensive, community-informed approach that integrates policy, systems, and environmental strategies alongside a whole systems perspective to assess obesity’s multifaceted determinants. By addressing the complex interplay of social, governmental, and environmental factors, our outcomes will align statewide efforts to reduce obesity and inform future multi-sector strategies for cancer prevention, targeting the unique challenges faced by Nebraskans.